NATURAL SIV &HIV TYPE 1 NEF ALLELES IN LYMPHOCYTE ACTIVATION

Previous work had indicated that an unusual allele of nef (17Y) was responsible for causing lymphocyte activation. We investigated alternate assays to score lymphocyte activating properties of natural nef alleles of SIV and HIV-1. A T lymphoid cell line termed 221 was derived from a rhesus monkey infected with herpesvirus saimiri. Growth of 221 cells was dependent on the addition of interleukin-2 (IL-2) to the culture medium. In the absence of IL-2, 221 cells arrested in G0-G1 but did not die. Simian immunodeficiency virus (SIV) replicated efficiently in IL-2-stimulated 221 cells whether or not the nef gene was present. In the absence of IL-2, nef-containing SIV replicated 8 to 100 times more efficiently in 221 cells than did the same virus lacking nef. nef-containing virus preferentially stimulated the production of IL-2 from 221 cells. HIV-1 nef and v-ras genes, but not the c-ras gene, were shown to substitute functionally for SIV nef when tested as recombinant viruses in this assay system. These results demonstrate a role for natural nef in causing lymphoid cell activation and they provide a system for delineating the biochemical mechanisms responsible for this activation.